Environmental Science Project 3 - Social Determinants of Risk and Attitudes About

Social determinants of risk and attitudes about asbestos in a Superfund Environmental Justice community: The broad objective of this proposal is to conduct an environmental epidemiologic and ethnographic study of asbestos-related disease among residents of Ambler, Pennsylvania, one of the largest asbestos waste sites in the US where there was substantial industrial and community exposure to asbestos from the late 1800s through the late 1980s. The known adverse health effects of asbestos exposure in work settings raise the possibility of analogous effects from community level exposure. The Pennsylvania Department of Health has identified in the Pennsylvania Cancer Registry an excess of cases of mesothelioma in the Ambler zip code, finding a 2.7 times higher than expected rate among men and a 4.5 times higher than expected rate among women. However, a combination of circumstances including out- migration of families from the area following closure of the asbestos industry, the long latency period characteristic of asbestos related diseases, the under-reporting of lung diseases in earlier periods, and the mismatch between administrative boundaries and actual exposure to asbestos, may have affected the ability of standard public health surveillance methods to fully capture the magnitude of the problem in this area. We propose to build on Department of Health findings and on our own previous pilot work in which we used ethnographic methods to delineate parameters of the relevant communities of exposure and to describe normative lifestyle patterns and circumstances of potential asbestos exposure. In the process of developing these data, we have formed strong relationships with these communities which will facilitate our access to current and past residents and workers to conduct a geographic case control study to analyze the contribution of community, occupational and social factors among individuals who developed mesothelioma. Specifically, we will determine the association between the development of mesothelioma and geographic proximity to the plant and asbestos waste piles that had been publicly discarded in the Ambler area. Our study design is based on the following hypotheses: 1). The incidence of mesothelioma is related to both occupational and non-occupational (community exposures) in the Ambler area; 2) There is an association between the incidence of mesothelioma and proximity of residence to the asbestos waste sites and 3) The relationships between proximity to the site and mesothelioma are modified by various social, lifestyle and economic factors that influence asbestos exposure. These hypotheses will be tested under the following Specific Aims: Aim 1) To utilize an ethnographic approach with residents to identify patterns of exposure related to lifestyle and social factors to inform the case control analysis. Aim 2) To identify, characterize and map all cases of mesothelioma in Ambler Borough and the four adjacent townships. Aim 3) To identify a set of controls that are frequency matched with cases based upon a minimum five year residence in the area . Aim 4) To use a geographic case-control design to characterize the contribution of geographic factors found among people who developed mesothelioma in the greater Ambler area.

Public health relevance
The broad objective of this proposal is to understand whether there is risk for development of mesothelioma from environmental, as opposed to occupational exposure to asbestos in settings such as those that exist in Ambler, PA where there are piles of asbestos waste materials in the community. We will first identify all cases of mesothelioma in the Ambler region and we will describe those cases in terms of age at diagnosis, occupation, sex, and location of residence and then we will identify a set of control cases, not diagnosed with mesothelioma who lived in the area and are old enough to have developed mesothelioma. We will compare the cases and controls and we will look to see if residence near the asbestos waste piles can account for mesothelioma cases that do not have any obvious occupational link.